Dynamics of exocyst recruitment and assembly

DESCRIPTION (provided by applicant): The long-term objective of these studies is to elucidate the mechanisms by which exocyst recruitment and assembly are involved in vesicle tethering, docking and fusion. The exocyst is an octomeric protein complex (Sec3/5/6/8/10/15/Exo70/84) that spatially targets vesicles to specific sites on the plasma membrane, such as the bud tip in yeast, where it was identified in a series of seminal studies. In mammalian cells it is responsible for a range of polarized cellular processes such as cell division, migration, stabilization of junctions and formation of a primary cilium. Despite the ubiquitous and essential role of the exocyst, there are critical gaps in understanding how the exocyst 'tethering' complex and other putative tethers function to anchor vesicles and coordinate with downstream SNARE-mediated fusion machinery. While tethers are believed to involve long-range interactions, be reversible and regulate the fidelity of vesicle fusion, these concepts are generally untested and there are few assays to monitor the dynamic changes in discrete biophysical and molecular states of the exocyst. Resolving these topics will include addressing the stoichiometry of the mammalian complex, assembly and disassembly of the exocyst holocomplex, and its coordination with the fusion machinery, all of which are key goals in the proposed studies. The specific aims of this study are: 1) to critically test the longstanding exocyst as a tether hypothesis and to study the dynamics of its recruitment to vesicles; 2) to address how the exocyst is able to biophysically promote docking and fusion; 3) to address how post-translational modifications of the exocyst affects its stability and regulates its function. These studies will provide new knowledge of how tethers function and establish a new platform to monitor their discrete states. Understanding the basic mechanisms of how the exocyst functions is highly relevant to human diseases, since its dysfunction is associated with metastasis of cancer cells, diabetes, and ciliopathies, and it is pathologically targeted by anthra toxin. A deeper understanding of how the exocyst functions as a tether and how it is regulated may help identify new molecular targets of intervention.

Public health relevance
PUBLIC HEALTH RELEVANCE: The exocyst is a protein complex that targets vesicles to the cell surface and plays an essential role in cell migration, release of hormones, and cell division. As such, its dysfunction contributes to diseases including polycystic kidney disease, diabetes and cancer. Our studies will address key mechanisms of how the exocyst works and is regulated, which may ultimately lead to new therapeutic strategies for treatment of these diseases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The targeting and fusion of vesicles is vital to all aspects of cell physiology: from hormone secretion to receptor recycling. The fusion machinery is well known, but how the 'tethers' capture and target vesicles to promote fusion, and how they are regulated, is obscure. This limits our ability to understand and manipulate exocytosis. Tethers, like the exocyst complex (3/5/6/8/10/15/70/84), capture vesicles upstream of SNAREs. Their function is assumed to end when SNAREs are activated to fuse the vesicle. This view is frequently found in reviews, but is untested. This gap in knowledge is because our current understanding of tether proteins is mainly based on genetics, in vitro binding studies, and X-ray crystal structures; none of these techniques can address the spatial-temporal relationship and stoichiometry between the vesicle, tethers, the docking site, and the fusion pore as they develop in sequence. We have begun precisely such an integrated study using quantitative imaging of fluorescently tagged exocyst subunits in mammalian cells, to image the spatial relationships of these proteins as the vesicle ultimately forms a fusion pore. We overcame technical roadblocks preventing visualization of FP-tagged tethers by increasing the sensitivity and specificity of the assays. We employ genetic criteria (siRNA and dominant mutations), and complementary biochemical assays, to assure that temporal and spatial correlations are causally required in the process. Based on our extensive preliminary data, or prior work, and the literature, we have developed a working model (figure) for the function of the exocyst in fusion at the plasma membrane. This process is vital for hormone secretion and cell polarity, while exocyst dysfunction contributes to diabetes and cancer. Our working hypothesis is that rather than acting solely upstream of SNAREs (the current model), the exocyst acts at every step from docking to fusion pore opening. In particular, the exocyst is required to initially tether the vesicle, as has long been postulated (and we now provide the first direct concrete evidence), which we propose is done in its "extended" conformation with multiple tethers; then it undergoes a dramatic conformational change to a "compact" structure that brings the tethered vesicle within molecular contact distance of the plasma membrane, thereby assisting SNAREs to engage (docking); then it acts to promote fusion pore opening (possibly by engaging Munc proteins). We hypothesize that phosphorylation of exocyst subunits (Sec5 and Sec8) regulate the conformation and stability of the complex, which tunes exocytosis; this occurs in series by PKC¿, and likely by other kinases (Akt), as a phosphorylation cascade. The key new observations that have led us to this hypothesis are: 1) tether subunits stayed connected to the vesicle until fusion pore expansion; 2) single molecule 'counting' showed that ~3 tether subunits were present at fusion; 3) phosphomimetic mutants of Sec8 (Ser32) promoted rapid expansion of the fusion pore. Our model guides and focuses our proposed research. We will critically test the model and its specific hypotheses (our 3 Aims), and in so doing validate, amend, or refute it. Specifically, our Aims are: 1. To directly test the hypothesis that the exocyst is a tether and is present until expansion of the fusion pore. Optogenetic assays will be used to control exocyst function and determine if it is required for vesicle tethering to the plasma membrane. Quantitative single vesicle analysis will be used to test the temporal persistence of exocyst subunits from initial vesicle arrival until full vesicle fusion. 2. To test the hypothesis that the exocyst acts as 'multiple molecular ratchets' to promote docking and fusion. We will use high-precision single vesicle tracking to test our hypothesis that 'docking' is an active process. We will use molecular counting to test how the number of tethers affects their function; based on our model we predict that a vesicle with a single tether (e.g. one Sec-RFP molecule) is less likely to fuse. 3. To test the hypothesis that an 'exocyst phosphorylation cascade controls the fidelity of vesicle tethering and fusion. We hypothesize that growth factors trigger an exocyst phosphorylation series in which PKC¿ (and possibly Akt) bound to Sec10 sequentially phosphorylates Sec5 and Sec8 to enhance docking and fusion. Our model predicts that phosphorylation of exocyst subunits acts in series, possibly as a cascade. We we will test this model by using Sec5 and Sec8 phospho-mimetic and non-phosphorylatable mutants. We will use functional screens and multicolor imaging to discriminate between models of exocyst assembly. The ability of the exocyst to influence the final step of exocytosis, fusion pore expansion, by phosphorylation of their subunits may provide a new mechanism of control. The associated kinases may lead to new therapeutics.